IRE1α mediated dysregulation of the pulmonary epithelium in lung fibrosis

Project Summary / Abstract
Idiopathic pulmonary fibrosis (IPF) is a disease of progressive interstitial fibrosis, which leads to severe
debilitation and eventually respiratory failure and death. Protein folding stress in the endoplasmic reticulum (ER
stress) triggers the unfolded protein response (UPR), which has been implicated in IPF. The most deeply
conserved mediator of the UPR is IRE1α, a bifunctional kinase/endoribonuclease that mediates XBP1 mRNA
splicing, degradation of ER-localized mRNAs (RIDD), and degradation of the microRNA miR-17. Under severe
ER stress, IRE1α hyperactivity promotes cell death, a condition termed the terminal UPR. A parsimonious view
holds that the terminal UPR causes ongoing alveolar epithelial cell death which leads ultimately to fibrosis.
The laboratory of Dr. Feroz Papa (co-mentor) developed and characterized Kinase Inhibiting RNase
Attenuator (KIRA) compounds that inhibit all the major functions of IRE1α. We previously showed that mice
treated with KIRA compounds were protected from bleomycin-induced fibrosis. In new preliminary data, a mono-
selective KIRA compound decreased miR-17 degradation, TGFβ signaling and the senescence-associated
secretory phenotype (SASP) in the lung epithelium after bleomycin. In fibrotic mouse lungs and human IPF lungs,
these IRE1α-regulated pathological gene signatures were preferentially found in dysfunctional progenitor cells.
These results challenge the current paradigm that the UPR contributes to fibrosis exclusively through cell death.
Instead, the central hypothesis of this proposal is that hyperactivation of IRE1α in injured epithelial
progenitor cells triggers a network of mutually reinforcing fibrotic pathways, including gene repression by miR-
17, senescence, and TGFβ signaling. Specific Aim 1 will test the hypothesis that IRE1α is necessary and
sufficient for epithelial progenitor cell dysfunction by interrogating the effects of chemical or genetic inhibition of
IRE1α in the bleomycin model and two genetic models of fibrosis based on senescence (Sin3a knockout) and
ER stress (SftpcC121G). Specific Aim 2 will test the hypothesis that IRE1α regulates progenitor cell dysfunction
through miR-17 using conditional deletion and conditional overexpression mice.
The training plan is focused on the skills and concepts of lung regeneration and developmental biology,
in vitro models of lung biology, epithelial cell dysfunction, and responsible laboratory management. Training will
include didactic courses, focused symposia, and international conferences. The primary mentor and co-mentor
are Dr. Dean Sheppard and Dr. Feroz Papa, both accomplished physician-scientists with long track records of
mentorship. Dr. Auyeung has laboratory and office space at the UCSF Mission Bay campus, a fertile environment
for collaboration with ready access to the facilities and equipment necessary for this research.
In summary this Career Development Award application merges an exceptional candidate, an innovative
and tractable research plan, rigorous training, and the support of world-class physician-scientists into a powerful
springboard for the launch of a productive and independent career with high impact on lung disease.

Public health relevance
Project Narrative Idiopathic pulmonary fibrosis (IPF) is a devastating disease of relentless scarring in the lungs, which leads to severe debilitation and eventually respiratory failure and death. The cause of IPF is not known, and there are few treatments available. This project explores one of the underlying mechanisms of IPF, and how manipulating a cellular stress response pathway might enable progenitor cells to repair the lung, rather than promote scar tissue.